MK2-mediated mechanisms of apoptosis during endothelial barrier disruption

PROJECT SUMMARY/ABSTRACT
Acute Respiratory Distress Syndrome (ARDS) remains a frequent occurrence in the intensive care unit
and is associated with high mortality. A crucial determinant of ARDS is endothelial cell (EC) apoptosis
leading to endothelial barrier dysfunction, increased vascular permeability, and resulting hypoxia.
Understanding the molecular mechanisms that regulate EC apoptosis following injurious stimuli is crucial
to improving outcomes in ARDS. Mitogen activated protein kinase activated protein kinase 2 (MK2) is part
of a critical stress activated protein kinase pathway that has been implicated in initiating the apoptotic
cascade, though how MK2 interacts with the apoptotic cascade is unclear. Activation of the apoptotic
cascade culminates in activation of the executioner caspase-3 (casp3). Published data from our lab has
demonstrated that MK2 phosphorylates casp3, and I have generated preliminary data showing the kinase
activity of MK2 potentiates casp3 activity in a model cell line. Interestingly, our lab has also identified that
MK2 directly binds with casp3 to facilitate nuclear transport and promote execution of apoptosis
independent of casp3 phosphorylation. In total, these data suggest MK2 interacts with the apoptotic
cascade and specifically casp3 in two distinct ways: it phosphorylates casp3 via its kinase function and
binds directly to casp3 for nuclear transport via a chaperone function. This application serves to provide a
training vehicle as I elucidate further details about these two distinct mechanisms. In Aim 1, I will
determine the role of MK2-dependent phosphorylation of caspase-3 in potentiating casp3 activation and
apoptosis during endothelial barrier disruption. In Aim 2, I will evaluate binding between the docking
region of MK2 and the putative binding domain of casp3 and the impact of this binding on nuclear
translocation of casp3 and subsequent apoptosis and endothelial barrier disruption. Investigating these
dual functions MK2 would provide novel mechanisms into the regulation of casp3 activity and execution of
apoptosis following injury, and possible identification of a therapeutic target to improve vascular barrier
integrity in ARDS. Through this proposal, I will learn not only highly specialized laboratory skills including
techniques to evaluate protein-protein interactions and endothelial cell isolation, but also biology of kinase
signaling and apoptosis. In addition, I will hone leadership and communication skills necessary for
academic career development. The data I generate will create a strong foundation for a future K08
application, with the goal of becoming an independently funded physician-scientist studying molecular
mechanisms of lung endothelial cell dysfunction in ARDS.

Public health relevance
PROJECT NARATIVE Acute Respiratory Distress Syndrome (ARDS) is a syndrome associated with high in-hospital mortality. A crucial determinant of ARDS is endothelial cell (EC) apoptosis leading to endothelial barrier dysfunction, increased vascular permeability, and resulting hypoxia. I will study the mechanisms by which the proteins mitogen activated protein kinase activated protein kinase 2 (MK2) and caspase-3 interact following injurious stimuli to promote endothelial cell apoptosis and endothelial barrier disruption.